Novel Transition Metal Catalysis for Chemical Synthesis

Project Summary
The proposed MIRA application aims at the development of a new synthetic platform for controlled selective
functionalizations of organic molecules. The existing synthetic methods toward complex molecules and
pharmaceuticals mostly rely on employment of pre-functionalized substrates. Employment of non-
functionalized groups is much more appealing, as these moieties are much more abundant and cheap.
Moreover, the aliphatic C(sp3)–H bonds are often present in complex biologically important molecules and
pharmaceuticals, and thus their selective functionalization offers a powerful tool for late stage modifications.
The few existing methods for functionalization of unactivated saturated groups are not general, as the
functionalization site is usually substrate-controlled. Also, these methods operate under acidic conditions
and/or employ external oxidants, which limits the substrate scope. Thus, mild regio- and stereo-controlled
functionalization of saturated groups remains a holy grail in modern synthetic chemistry. We propose the
development of a novel visible light-induced transition metal-radical hybrid catalytic methodology for
regiocontrolled, mild, and exogenous oxidant-free functionalizations of saturated groups. The site of
intramolecular functionalizations will be controlled by a designed tool-kit of temporary auxiliaries, which
potentially in one-pot fashion will be routinely installed onto substrate and removed from the product. The
chemo- and stereoselectivity of intermolecular functionalizations will be achieved via design of potent and
selective hydrogen atom abstracting groups. The feasibility of a successful development of this project is
supported by a vast amount of preliminary results obtained in our lab.

Public health relevance
Narrative The proposed work aims at developing new methods for selective and efficient conversion of simple and abundant molecules into functionalized compounds of biological importance, as well as late-stage functionalization of complex molecules and drugs. The proposed approaches rely on employment of hybrid transition metal-catalyzed radical methodologies, including desaturation, atom transfer, cross-coupling, and cascade functionalization techniques. If fully developed, these methods would dramatically broaden the arsenal of synthetic tools available for medicinal chemists and biologists, and will most certainly impact drug discovery research and related health-oriented sciences.